Vaping α-T-acetate Generates a Novel Toxic Compound that Induces Fever and Lung Inflammation

Vaping has become popular among teens and young adults. It has been reported that an acetate conjugate of
vitamin E, α-tocopherol-acetate (α-T-acetate), has been added to some base e-liquids for vaping. α-T-acetate in
e-liquids is linked to E-cigarette, or vaping associated lung injury (EVALI) and deaths. There were 2,807 illness
and 68 deaths (by October 2020) associated with vaping. α-T-acetate is in the bronchoalveolar lavage of EVALI
patients, and vaping α-T-acetate and other acetate conjugates is still occurring. Patients with EVALI have lung
symptoms of cough, shortness of breath, or chest pain, as well as fever, nausea, vomiting, diarrhea, fatigue or
weight loss. EVALI patients have elevated systemic inflammatory mediators and lung remodeling. The CDC
suggested that the lipid α-T-acetate not be added to vaping products until mechanistic studies are done. We
propose novel mechanisms for manifestations of EVALI from vaping α-T-acetate. Our novel preliminary data
indicate that a novel high molecular weight compound is generated from vaping α-T-acetate and that this
compound would not be detected in the LC-MS approaches in previous reports on vaped compounds. The novel
compound was toxic to epithelial cells, induced eosinophilia, fever and overt lung remodeling in mice, but did not
lipid-load lung macrophages. In contrast, non-vaped α-T-acetate in base e-liquids do lipid-load lung
macrophages but this does not induce fever. Although, we show that a high molecular weight toxic compound is
generated and we have separated the compound, the structure of the toxic compound, and the mechanisms for
induction of fever, lung damage and lung inflammation by this novel compound are not known. Our novel
concept is that a novel high molecular weight compound is generated from vaping α-T-acetate that is highly
toxic to epithelial cells, without lipid-loading of macrophages. Our long term goal is to identify mechanisms for
effects of vaping α-T-acetate on lungs and fever in youth and adults with EVALI. As a step towards our long-
term goal, our central HYPOTHESIS is that vaping α-T-acetate generates a novel high molecular weight toxic
compound that induces lung inflammation, lung damage and fever in youth and adults, without lipid-loading lung
macrophages. We will test this with the following aims: Aim 1. Test the hypothesis that a novel high molecular
weight compound is generated from vaping α-T-acetate as assessed by mass spectrometry (MS), chemical
structure modeling and NMR. Aim 2. Test the hypothesis that a novel compound, generated by vaping α-T-
acetate, induces fever, lung damage, lung inflammation and reduces lung function, without lipid-loading of lung
macrophages. We will also assess regulation of these manifestations by the early recruitment of lung eosinophils.
Completion of these studies 1) will have a significant impact on our understanding of mechanisms of vaped α-T-
acetate-induced lung damage and inflammation and 2) may lead to design of future human studies for
interventions that significantly impact risk for EVALI and death from vaping in youths and adults.

Public health relevance
PROJECT NARRATIVE Our long term goal is to identify mechanisms for effects of vaping α-T-acetate on lungs and fever in youth and adults with EVALI. As a step towards our long-term goal, our central HYPOTHESIS is that vaping α-T-acetate generates a novel large molecular weight toxic compound that induces lung inflammation, lung damage and fever in youth and adults, without lipid-loading lung macrophages. Completion of these studies 1) will have a significant impact on our understanding of mechanisms of vaped α-T-acetate-induced lung damage and inflammation and 2) may lead to design of future human studies for interventions that significantly impact risk for EVALI and death from vaping in youths and adults.